New Risk Models for Diabetes Complications Using Electronic Health Records

Abstract
Diabetes incidence and prevalence remain at record highs in the United States. Understanding
diabetes disease progression and how it varies among America’s heterogeneous population is critical, given
unequal risks and outcomes for individuals of different racial/ethnic groups. Diabetes outcome prediction and
simulation models allow prediction of a person’s risk for diabetes complications and death. A recent review of
19 such models found that the majority—16 models—relied at least partly on transition functions developed by
the United Kingdom Prospective Diabetes Study (UKPDS). The UKPDS draws on data from a trial that began
in 1977 and involved 5100 patients who were followed for a total of 89,760 person years. The sample
consisted of mostly white British citizens. Only 8% and 10% of the UKPDS sample were Indian Asian and Afro-
Caribbean patients, respectively. The major racial/ethnic groups that make up the US population were not
included, and the variables studied in the UKPDS did not include any behavioral data. Long term, longitudinal
patient data on diabetes outcomes is costly to collect and all information on the UKPDS Outcomes Models has
been transparently reported and made publicly available. This has left the UKPDS risk models as the best
option for many risk engines, despite the small, dated and nondiverse sample that it is based on.
Capitalizing on Kaiser Permanente Southern California (KPSC) Electronic Health Records (EHR) data
and legacy data systems, we identified over 527,000 patients with incident diabetes that were diagnosed and
treated at KPSC from 1993 to 2020. Our sample provides more than 4.4 million person-years of follow up.
More than 34,000 patients could be followed up for 21 or more years. The incident diabetes cohort from KPSC
is 34.4% Hispanic, 10.6% Asian and 12.7% African American or Black allowing us to update the risk equations
for all UKPDS outcome models by major race-ethnicity groups directly relevant for the U.S population. These
updated models will allow us to identify disparities in diabetes, assure statistical fairness, and improve
prediction of diabetes outcomes for diverse population groups.
Because diabetes outcomes are largely influenced by health behaviors, we will also analyze behavioral
data captured in the EHR including data on exercise and referrals to diabetes and weight management
education classes. We will use cutting edge parametric, semi-parametric and non-parametric models to re-
estimate risk equations using standard split sample cross-validation. We will report our methodology and
results transparently in the same format as the UKPDS. Our study will help to update existing simulation
models and support more timely and equitable clinical decision support and patient education.

Public health relevance
Narrative We use Electronic Health Records (EHR) data of over 527,000 patients with incident diabetes who were diagnosed and treated in the Southern California Kaiser Permanente (KPSC) health care system from 1993- 2020 to update the United Kingdom’s Prospective Diabetes Study (UKPDS) risk equations. KPSC’s diverse and vast membership further allows us to estimate UKPDS risk equations separately for major racial/ethnic groups. We will also explore the impact of health behaviors on diabetes trajectories including exercise and referrals to diabetes and weight management education classes.